Protein Organelles in Human-Associated Bacteria

Cellular compartmentalization is a defining feature of life. Similar to eukaryotes, many prokaryotes
compartmentalize their cytosol to carry out specialized metabolic reactions, prevent toxicity and store nutrients.
However, prokaryotes rely on protein-based organelles instead of membrane-based compartmentalization
strategies. A semipermeable protein shell creates a sequestered reaction space separated from the bulk
cytosol. This compartmentalization can increase the local concentrations of enzymes and metabolites, prevent
the leakage of toxic or volatile intermediates and create unique reaction environments. Protein organelles
enable specialized biochemistry not possible without compartmentalization and have been implicated in carbon
fixation, iron metabolism, nutrient utilization and stress resistance. Protein organelles are present in nearly all
bacterial and archaeal phyla and can be found in many important human pathogens. Protein organelles have
been suggested to enable pathogens to utilize alternative nutrients and withstand the human immune system.
The two main classes of microbial protein organelles are encapsulin nanocompartments (20 to 50 nm) and
bacterial microcompartments (40-500 nm). In both cases specialized enzymatic machinery is selectively
encapsulated within self-assembling protein shells leading to unique catalytic capabilities. The overall goal of
my laboratory is to explore and understand the functional diversity of protein organelles encoded in microbial
genomes and to investigate their contribution towards human health and disease. Hundreds of microbes
encode uncharacterized protein organelle systems, some of which have been shown to contribute to microbial
virulence. However, the molecular and physiological functions of most protein organelle systems have not
been explored while their contributions towards human health and disease are poorly understood. The goals of
this proposal are to (1) carry out a detailed mechanistic and structural analysis of the major classes of protein
organelles, (2) determine how protein organelles contribute towards microbial stress resistance and
detoxification capabilities, and (3) investigate how protein organelles enable microbes to optimize nutrient
utilization. Based on our expertise and pioneering investigations of encapsulin systems, we are uniquely
positioned to successfully pursue the research described in this proposal. We will use a multifaceted approach
including biochemistry, structural biology, and microbiology to dissect the molecular mechanisms underlying
protein organelle function and elucidate how these megadalton protein assemblies influence human health and
disease. This information will be essential for exploring future therapeutic approaches aimed at disrupting
protein organelle function to reduce microbial stress resistance and fitness and thus pathogenicity. The
detailed characterization of protein organelles will also lay the groundwork for future protein organelle
engineering with applications in biomanufacturing, biomedicine and bionanotechnology.

Public health relevance
The research outlined in this proposal will lead to new fundamental insights into the functioning of complex megadalton protein assemblies and illuminate the role protein organelles play in microbial metabolism, stress resistance, nutrient utilization and pathogenicity. This research will lay the groundwork for future therapeutic approaches aimed at disrupting protein organelle function to reduce microbial stress resistance and fitness and thus pathogenicity. Additionally, this work will generate the necessary fundamental knowledge for engineering protein organelles for future biomedical applications ranging from improving the biological production of drugs to drug delivery and bioimaging.